7-deazaguanines in DNA: mechanism and structure of complex genome modification

SUMMARY. Enzymatically-directed nucleotide modification is a key component of nucleic acid
processing and is used by all organisms to address a multitude of fundamental needs in
information transfer systems, including protection of DNA, translational fidelity, RNA stabilization,
and epigenetic regulation. In a remarkable example of the cross-talk between RNA and DNA
processing, we recently discovered that one of the most complex modification systems known to
occur in RNA, that responsible for the 7-deazaguanine modifications queuosine (Q) and
archaeosine (G+), is also utilized by diverse organisms for the modification of DNA. Indeed, in
Bacteria a set of roughly 10 proteins comprise an elaborate restriction-modification (RM) system
based on the formation of 2’-deoxy-7-cyano- and 2’-deoxy-7-amido-7-deazaguanosine (dPreQ0
and dADG, respectively) in DNA, and these nucleosides, as well as dG+ and 2’-deoxy-7-
aminomethyl-7-deazaguanosine (dPreQ1), have also been found in the DNA of phage and
archaeal viruses. Having identified the relevant proteins involved in the formation of 7-
deazaguanine based DNA modifications, we are now proposing to elucidate the molecular basis
for their function. The research described in specific aims 1 & 2 address the modification
machinery in bacteria, the proteins DpdA, DpdB, and DpdC, which together are responsible for
the formation of dPreQ0 and dADG, and serve as a model for 7-deazaguanine based modification
in DNA. In specific aim 3 we take a broader look at the DpdA family and consider systems that
lack DpdB and contain DpdAC fusions, as well as a phage DpdA in order to better understand
the need for the cryptic ATPase activity of DpdB in bacterial modification, and the structural basis
of sequence specificity in the bacterial and viral systems.

Public health relevance
PROJECT NARRATIVE. The Dpd restriction-modification (RM) system is a newly discovered RM system widely distributed in bacteria and based on the formation of 7-deazaguanosine derivatives in DNA. The work described in this proposal will lead to a molecular-level understanding of the roles of the Dpd proteins in complex DNA modification, and lay a foundation for the development of new biotechnological tools.